CORE--CELL CULTURE

The SCOR is dependent upon the isolation, purification, and maintenance of airway cells, cell lines and lung tissue for the study of lung development and repair. The Tissue Culture Core takes advantage of long- established expertise In isolation and purification of defined lung cell populations. This Core will generate purified cultures of alveolar Type II cells, alveolar macrophages, lung fibroblasts and fetal Type II cells from wild-type and transgenic mice with quality control procedures to ensure uniformity of experiments and lack of pathogenic contamination. Timed pregnant mice will be used to generate fetal lung explant cultures in a coordinated fashion for the SCOR projects. Cultures of MLE-12, MLE- 15, ES, 3T3, HeLa, MH-S, BSMC and MFLM cell lines will be cryopreserved and maintained to ensure availability of cultured cells for the SCOR projects. This Core will also provide tissue culture support services to SCOR investigators to ensure uniformity of culture conditions and application of appropriate quality control measures screening for mycoplasma and cell phenotype. Techniques to increase the yield and purity of cell and tissue preparations will be continuously evaluated by Core personnel to increase the quantity of material available to the SCOR. The Tissue Culture Core will provide material in an efficient and uniform manner.